An Adaptable Platform to Promote Patient Health Through Adherence to Treatment and Prevention

Project Summary/Abstract
Minnesota HealthSolutions Corporation in collaboration with the Mayo Clinic proposes to develop an adaptable
platform to support patients with behavior change to improve adherence to treatment and prevention for
multiple chronic diseases. The proposed platform will utilize remote monitoring combined with health coaching
to create behavior change aimed at improving self-management and quality of life. Chronic diseases are the
leading cause of disability and death worldwide and an estimated one in three adults has one or more chronic
conditions. Self-monitoring of many chronic conditions has become common and mobile health interventions
have proliferated. Yet the effectiveness of many such interventions has not yet been thoroughly assessed.
Additionally, the increase in mobile health interventions has highlighted disparities and barriers to its use.
Minnesota HealthSolutions and the Mayo Clinic have previously collaborated to develop an effective home-
based pulmonary rehabilitation system that provides remote monitoring and health coaching to promote self-
management. The system has been evaluated in two large randomized controlled trials and shown significant
results in both adherence and outcomes. We believe that an adaptable system can be created that can be
utilized to address many common chronic conditions. The proposed system will be cost-effective, scalable, and
feasible for widespread implementation for chronic diseases.

Public health relevance
Project Narrative Chronic diseases are the leading cause of death and disability worldwide and are often comorbid with each other. Mobile health interventions offer the possibility of supporting patients in chronic disease self- management, potentially reducing health care utilization and eliminating disparities in health care access. While mobile health interventions have proliferated, few have been evaluated for efficacy and many fail to meet recommended standards.